Genetic dissection of color-vision circuits

Visual animals utilize spectral information in two ways: true color vision, which differentiates spectral compositions largely independent of brightness, allows animals to recognize objects and register and retrieve color memory; innate spectral preference, which is intensity-dependent and learning-independent, reflects individual species' specific ecological needs. Using a combination of genetic, histological, electrophysiological, imaging and behavioral approaches, our group studies how visual circuits process chromatic information to guide behaviors in Drosophila. Our strategy is (i) to identify key neuronal types and to map their synaptic connections, (ii) to examine functional requirement of identified neurons for color vision and spectral preference behaviors, and (iii) to determine the synaptic mechanism that transform visual signals at different processing stages. By molecular genetics and histology, we mapped the synaptic circuits of the chromatic photoreceptors, R7s and R8s, and their synaptic target neurons, Tm and Dm neurons, in the peripheral visual system. The medulla projection (Tm) neurons (Tm5a/b/c, Tm9 and Tm20), analogous to vertebrate retinal ganglion cells, relay photoreceptors to higher visual centers while the Dm (Dm8) neurons provide an indirect pathway by relaying photoreceptors to Tm neurons. To probe the synaptic connections between these identified neurons, we developed two modified versions of GRASP (GFP reconstitution across synaptic partners) methods: an activity-dependent GRASP based on split-GFP-tethered synaptic proteins and a receptor-based GRASP based on split-GFP-tethered neurotransmitter receptors. Using these methods, we found that the chromatic photoreceptors, R7 (UV-sensing) and R8 (blue/green-sensing), provide inputs to a subset of first-order interneurons. Tm9/20/5c and Tm5a/b receive direct synaptic inputs from retinotopic R8s and R7s, respectively, consistent with their functions in processing single visual pixel information. In contrast, the amacrine neuron Dm8 pools inputs from 14 R7s and provides input for Tm5c. To assign neurons to innate spectral preference, we systematically inactivated different first-order interneurons and examined behavioral consequences. We have previously found that the amacrine Dm8 neurons, which receive UV-sensing R7 photoreceptor inputs, are both required and sufficient for animals' innate spectral preference to UV light. We further found that inactivating Tm5c, one of Dm8s synaptic targets, abolished UV preference, indicating that Tm5c is the key downstream targets for spectral preference. Both the single-cell transcript profiling and immunohistochemistry revealed that both Dm8 and Tm5c express vesicular glutamate transporter (VGlut). RNAi-knockdown of VGlut in Dm8 or Tm5c significantly reduced UV preference, suggesting the critical functions of the glutamatergic output of Dm8 and Tm5c. We further identified that Tm5c expresses four kainite-type glutamate receptors and that RNAi-knockdown of these receptors, thus preventing Tm5c from receiving Dm8 inputs, significantly reduced UV preference. Thus, the R7s->Dm8->Tm5c connections constitute a hard-wired glutamatergic circuit for detecting dim UV light. Two-photon calcium imaging of Dm8 and Tm5c expressing the calcium indicator GCaMP6f revealed that the activity of both neurons are suppressed by full-field UV light illumination. The light responses of Dm8 are dependent on R7 activity and Dm8s expression of the histamine chloride channel ORT, indicating that Dm8 conveys sign-inverted signal via ORT. In contract to UV preference, color vision in flies appears to be mediated by multiple and partially redundant pathways. To identify color-vision circuits, we developed a novel aversive operant conditioning assay for intensity-independent color discrimination. We conditioned single flies to discriminate between equiluminant blue or green stimuli. We found that wild-type flies can be trained to avoid either blue or green while mutant lacking functional R7 and R8 photoreceptors can not, indicating that the color entrainment requires the function of the narrow-spectrum photoreceptors R7s and/or R8s. Inactivating four types of first-order interneurons, Tm5a/b/c and Tm20, abolishes color learning but inactivating different subsets of these neurons is insufficient to block color learning, suggesting that true color vision is mediated by parallel pathways with redundant functions. The apparent redundancy in learned color discrimination sharply contrasts with innate spectral preference, which is dominated by a single pathway, R7s->Dm8->Tm5c. The Tm5a/b/c and Tm20 neurons relay photoreceptor signals to the higher visual center, the lobula, which in insects has been implicated in processing and relaying color information to the central brain. To determine how color information is processed in the higher visual center, we set out to identify the lobula neurons that receive direct synaptic inputs from the chromatic Tm neurons, Tm5a/b/c and Tm20. We first collected and characterized 28 Gal4 lines for their expression in various lobula neurons. Second, we used our modified GRASP method to examine potential contacts between chromatic Tm neurons and the dendrites of candidate lobula neurons. We identified four types of lobula neurons that form synaptic contacts with chromatic Tm neurons: two novel lobula intrinsic neurons, Li3 and Li4, and two lobula projection neurons, LT11 and LC14. Each LT11 elaborates a large dendritic tree to cover the entire lobula layers, Lo4-6, and projects an axon to optic glomeruli in the central brain. Each Li4 extends dendrites to cover about 60% of the lobula layer, Lo5 while each Li3s dendrites cover about 15% of the lobular layers 5 and 6. Using the single-cell GRASP method we developed, we further characterized the synaptic connections at the single-cell resolution and found that both Li4 and LT11 neurons receive inputs from all four chromatic Tm neurons but LT11 appears to prefer Tm5a neurons. To confirm synaptic connections observed at the light microscopic level, we developed a two-tag EM double labeling technique that highlights both presynaptic and postsynaptic terminals in the same preparation for EM analysis. By combining two orthogonal expression systems and two different peroxidases, HRP (horse radish peroxidase) and APX (ascorbate peroxidase), we expressed HA-tagged mitochondrion-targeted APX in Tm5c and membrane-tethered HRP in their postsynaptic neurons LT11 and confirmed appositions among synaptic profiles. Our anatomical study suggests that the lobula neurons integrate multiple chromatic inputs from Tm neurons over a large receptive field.